NONHUMAN PRIMATE STUDIES OF METHAMPHETAMINE/HEROIN ABUSE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Substance abuse continues to be a persistent epidemic that evades effective treatment. Multiple dependencies present a further challenge because of the need to treat different psychological and physiological effects of the different substances. This proposal has the potential to distinguish the biological basis of individual effects of METH and heroin abuse and reveal how they act in tandem to produce a speedball effect. Understanding the pharmacology of speedball reward will lead to the precise brain targets for which medications can be developed to counteract the rewarding effects of speedballs and consequently reduce the prevalence of speedball dependence.